Understanding the role of estrogen receptor expression in CVD risk in women with and without HIV

PROJECT SUMMARY/ABSTRACT
With this K23 Mentored Patient-Oriented Research Career Development Award, I will develop the skills
necessary to become an independent clinician-scientist focused on the pathogenesis of end-organ disease in
women living with HIV (WLWH). My background in clinical Infectious Diseases and a Master of Science in
Clinical Research have provided a foundation for this work, which will leverage the resources of the Atlanta
Women’s Interagency HIV Study (WIHS) and Emory Specialized Center of Research Excellence (SCORE) on
Sex Differences. During this Award, I will be mentored by Dr. Igho Ofotokun, an HIV translational researcher
and PI of the Atlanta WIHS and SCORE, Dr. Gretchen Neigh, a basic scientist with experience in sex hormone
biology, and Dr. Arshed Quyyumi, a cardiologist and researcher with extensive experience in translational
vascular studies. I will complete advanced coursework in longitudinal data analysis, hands-on training in
laboratory methods to measure estrogen receptor gene expression and translation, vascular function, and
carotid artery wall thickness, and receive directed mentorship in CVD pathogenesis in women, sex hormone
biology, and HIV clinical research. HIV is a risk factor for CVD, and young women living with HIV (WLWH)
have an especially high risk for CVD compared to their HIV-uninfected counterparts. The mechanisms behind
this phenomenon are poorly understood, but we postulate that differences in estrogen activity may play a role.
Our prior work showed that CRP, a biomarker associated with CVD in the general population, does not predict
subclinical CVD progression in WLWH, as it does in HIV-uninfected women, suggesting that there is a different
mechanism driving the pathogenesis of CVD in WLWH, possibly related to estrogen activity. Estrogen affects
inflammatory pathways via its interactions with estrogen receptor (ER) and ER, which are encoded by the
genes ESR1 and ESR2, respectively. We found that the association between ESR1 and ESR2 expression on
PBMCs and carotid intima-media thickness differs by age and HIV status in women in WIHS. We hypothesize
that ESR1 and ESR2 expression and translation into ERα and ERβ is lower in WLWH than in HIV-negative
women, and reduced ESR1 and ESR2 expression and translation are associated with greater subclinical CVD
prevalence and progression. We propose a cohort study of virologically suppressed WLWH and at-risk HIV-
negative women with the following aims: 1) To determine the effect of HIV infection in ESR1 and ESR2
expression and translation on PBMCs over time, 2) To determine if ESR1 and ESR2 expression and
translation predicts prevalent subclinical CVD as measured by carotid artery wall thickness, endothelial
dysfunction and arterial stiffness, and 3) To determine the association between ESR1 and ESR2 expression
and translation in and subclinical CVD progression. Leveraging ongoing cohort studies that are actively
recruiting will greatly enhance the feasibility of these aims. Completion of these aims will separate me
scientifically from my mentors and position me to transition to independence as a clinician-scientist.

Public health relevance
PROJECT NARRATIVE HIV infection, even when controlled with antiretroviral therapy, is a risk factor for cardiovascular disease (CVD), which occurs at younger ages in persons living with HIV than in the general population. Women living with HIV are at an even greater relative risk for CVD than men when compared to women and men of similar ages in the general population, possibly due to differences in estrogen levels and estrogen receptor function in women with and without HIV. The proposed research will explore the effects of HIV on estrogen receptor gene expression and translation in women, and will look the associations of estrogen receptor gene expression and translation with prevalent and progressive subclinical CVD in women living with and without HIV.